Fluorescence-based detection of inflammation and necrosis to inform surgical decision-making and enhance outcomes

Project Summary: Tissue necrosis is a form of cell death caused by a wide variety of diseases and
injuries. Current methods of detecting tissue necrosis to guide surgical decision making are limited. In burn
injury, clinical visualization of tissue necrosis is the standard of care; however, it is an imprecise method that
can result in delays in care, unnecessary surgery, and removal of viable tissue. There is a critical need to
identify novel methods to improve the detection of necrosis in burn injury to aid perioperative clinical decision
making. While Indocyanine Green Angiography (ICGA) has been shown to identify burn depth using perfusion
as a surrogate marker for necrosis, it has not been widely adopted for clinical decision making. Recently,
clinical trials using delayed imaging of high dose ICG (Second Window Indocyanine Green - SWIG) have
shown promise in image-guided surgical resection of tumors. We propose that SWIG imaging can be
employed to enhance surgical decision-making in burn injury, as well as in many disease processes
involving necrosis. The knowledge gained from this project will fill the critical need to prevent unnecessary
surgery, improve surgical precision, and provide insight into ICG localization in inflamed and necrotic tissue.
The goal of this project is to characterize the SWIG fluorescence in burn inflammation and necrosis on a
macroscopic and microscopic level. Specific Aim 1 will characterize fluorescent signals from SWIG in the
healing potential of indeterminate depth burns in humans. Specific Aim 2 will examine the association
between SWIG fluorescence and depth of necrosis in surgically excised burns. Specific Aim 3 will quantify
ICG fluorescence in inflamed, necrotic, and healthy human cells and tissues to determine substrate
localization. To attain our goal, we will use a team science approach including a burn surgeon scientist who
has extensive experience in human thermal injury models and clinical expertise in the surgical care of burn
patients along with imaging experts who have a track record for developing advanced fluorescence-based
technologies for in vivo imaging, including a surgical imaging technology called “transient lighting” that allows
simultaneous white light and low-level fluorescence visualization in ambient lighting conditions. Transient
lighting is especially critical in burn surgery to augment the visualization of the wound with ICG fluorescence
under full white lighting.
This project will result in preclinical and clinical data testing of ICG for direct detection of necrotic tissue
using a fluorescence imaging device optimized for burn surgery, while developing a platform for quantification
of tissue necrosis and characterization of ICG-avid necrosis. These studies will provide necessary data to
inform the design of a larger clinical trial to determine the efficacy and validity of ICG fluorescence-guided
clinical decision making to improve outcomes for burn patients.

Public health relevance
Project Narrative The proposed project investigates fluorescence image-guided surgery to allow precise identification of necrotic tissue both preoperatively and intraoperatively in burn patients. Furthermore, it uses a multi-model approach to elucidate the localization of indocyanine green in inflammation and necrosis to determine how this novel use of a well-known fluorescence marker can be optimized to aid in surgical decision making. This proposal will provide the necessary data to support the design of a larger clinical trial to study the feasibility and efficacy of this technology to improve the precision of necrosis detection and removal and improve wound healing outcomes.